Cardiology and Pulmonary Clinical Research Training Program

PROJECT SUMMARY
The Cardiovascular Medicine Division and Pulmonary, Allergy, and Critical Care Division, both of the
Department of Medicine; the Division of Cardiology and Division of Pulmonary Medicine, both within the
Department of Pediatrics; and the Center for Clinical Epidemiology and Biostatistics (CCEB), propose to
continue and enhance an innovative, rigorous, and successful two- to three-year research training program for
clinicians in both adult and pediatric cardiology and pulmonary clinical research.
The training program focuses on mentored research with an experienced investigator that involves didactic
training and the planning, design, conduct, analysis, and interpretation of an independent research project in
cardiology or pulmonary clinical research, all intended to be the next step in a trainee's academic career
preparing him/her for a career as an independently funded researcher. Trainees matriculate in the Master of
Science in Clinical Epidemiology (MSCE) program. Didactic coursework consists of required courses in
epidemiology and biostatistics, the basic sciences of high quality clinical research, methodology in
cardiopulmonary science, including courses in cardiopulmonary epidemiology, advanced epidemiology,
protocol development, sophisticated biostatistics, and elective courses relevant to the trainees' methodologic
interests. The training program is enhanced by journal clubs and clinical research conferences conducted by
participating faculty; instruction in the responsible conduct of research; and a professional development series.
The program will: 1) train clinicians to be rigorous and independent academic investigators able to use the
range of approaches available in epidemiology to address research issues in cardiovascular and pulmonary
diseases; 2) provide closely mentored research experiences with faculty preceptors in clinical epidemiology
and cardiovascular and pulmonary medicine; and 3) strengthen the links between epidemiology and
cardiovascular and pulmonary medicine.
Strengths of the proposed program are: 1) the long and continued history of successful research training
programs in the adult and pediatric cardiology and pulmonary divisions using the structure provided by the
CCEB, including this training program; 2) the collaborative links that have been forged among faculty with
interests in clinical research in cardiovascular and pulmonary diseases; 3) the comprehensive course offerings
and research programs that are available to trainees; and 4) an extensive set of experienced and
multidisciplinary faculty mentors with successful training records. The broad training program in the CCEB also
provides an ideal environment for collaborative learning and growth. Finally, The University of Pennsylvania
and the Perelman School of Medicine promote an academic environment in which basic, clinical, and
translational research are encouraged and viewed as attractive career paths for physicians.

Public health relevance
PROJECT NARRATIVE There is a national shortage of qualified clinician-scientists able to conduct the rigorous clinical research needed to address cardiovascular and pulmonary diseases. This training program proposes to continue to address this shortage through the efforts of a distinguished, experienced, and committed training program faculty. Training will continue to be provided to those who desire careers as clinician-scientists focusing on cardiology and pulmonary clinical research through a program that provides trainees with the skills needed to design, conduct, and complete epidemiologic studies that will address the most vexing population-based questions in cardiovascular and pulmonary medicine.